Macrophage Cell Subset Specific Biomarkers for Disease Prognosis in Biliary Atresia

PROJECT SUMMARY: Biliary atresia (BA) is a cholestatic liver disease of infancy that is the leading cause of pediatric liver transplantation. While evidence supports a role for an aberrant immune response in the pathogenesis of BA, the exact mechanism of disease remains unknown. This gap in scientific knowledge limits identification of immune biomarkers at diagnosis to stratify patient prognosis. While macrophages (MΦ) have previously been implicated in both human and murine BA, MΦ are heterogeneous by nature and the pathogenic subsets required for ongoing hepatic injury have not been identified. Overcoming this gap in scientific knowledge will identify the BA-specific pathogenic MΦ subsets and lead to novel cell-subset specific biomarkers predictive of patient prognosis. We have been the first to identify 3 novel hepatic MΦ subsets in pediatric cholestatic liver disease at the time of liver transplant that are distinct from non-diseased MΦ by leveraging the ability of single cell RNA-sequencing (scRNA-seq). We have defined these MΦ subsets as lipid-associated MΦ (high expression of genes involved in lipid metabolism), monocyte-like MΦ (expression of genes also identified in monocytes), and adaptive MΦ (enrichment for genes involved in lymphocyte activation). Furthermore, monocyte-like and adaptive MΦ subsets positively correlate with the poor prognostic signature at diagnosis established by Luo et al suggesting these subsets may drive fibrosis and activation of CD8-positive T cells implicated in disease outcome. We thereby hypothesize that serum cytokine networks drive MΦ polarization towards pathogenic monocyte-like and adaptive MΦ subsets; increased numbers of these MΦ subsets by histology at diagnosis will be associated with poor outcome. To investigative this hypothesis we will: 1) determine if the numbers of lipid-associated, monocyte-like, and adaptive MΦ at diagnosis in human BA correlate with outcome as defined by clearance of jaundice by 3 months post-Kasai Portoenterostomy (KPE), and 2) define MΦ-specific cytokine networks in serum that correlate with prognosis and histologic findings. This innovative research plan applies findings from previous scRNA-seq analysis to human samples available from ChiLDReN to identify MΦ-subset specific histologic and serum biomarkers for prognosis at the time of diagnosis. Findings from the study will advance the care of patients with BA and allow for improved prognostic counseling at the time of KPE.

Public health relevance
PROJECT NARRATIVE: Biliary atresia (BA) is a cholestatic liver disease of infancy that is the leading cause of pediatric liver transplantation. Evidence supports a role for the immune system, particularly the macrophage cell, in progressive liver damage, however, early immune predictors of outcome have not been developed. In the current study, we will be the first to define macrophage-specific markers at diagnosis that correlate with patient outcome and improve early risk stratification in BA.